ETIOLOGY OF CIRCADIAN RHYTHM SLEEP DISORDERS

We hypothesize that the circadian rhythm sleep disorders are caused by mutations in the human homologs of animal circadian clock genes. We plan to sequence these genes in patients and do a case-control genetic association study.